Understanding the role of Ngo1049 in subverting host-mediated metal starvation in Neisseria gonorrhoeae

Abstract
Neisseria gonorrhoeae (Ngo) is an obligate human bacterial pathogen that causes the sexually transmitted
infection gonorrhea. Due to increasing rates of gonorrhea and increased antibiotic resistance, vaccines and new
therapeutics are urgently needed. A promising strategy is targeting nutrient metal acquisition systems since they
are usually conserved, expressed during infection, and essential for bacterial survival in vivo. Ngo undermines
host metal restriction mechanisms by expressing outer membrane transporters to acquire essential metals from
human metal-sequestering proteins such zinc from calprotectin and psoriasin and iron from lactoferrin and
transferrin. However, many gene products that support Ngo growth in metal-limiting conditions remain
uncharacterized. We found that the product of the ngo1049 gene is highly expressed in Ngo grown under zinc-
limiting conditions. Ngo1049 is conserved among pathogenic Neisseria, and bioinformatic analysis predicts that
Ngo1049 is a metal-binding transferase localized in the periplasm. A Zur binding motif was identified upstream
of ngo1049, suggesting expression is regulated by Zur (zinc uptake regulator), which represses expression in
high zinc concentrations. ngo1049 transcripts are highly induced during Ngo infection of human endocervical
cells, indicating a potential role for Ngo1049 in Ngo pathogenesis. Based on these findings, I hypothesize
Ngo1049 is a Zur-regulated protein that facilitates zinc acquisition in metal-limited conditions at inflamed
epithelial surfaces. To test this hypothesis, in this F31-Diversity submission I propose to determine the
localization and regulation mechanism(s) of Ngo1049. Second, I will examine the contribution of Ngo1049 to zinc
acquisition in metal-limiting conditions. Lastly, I will define how Ngo1049 enables Ngo survival at inflamed
mucosal surfaces after exposure to epithelial cells and human immune cells that contain metal chelating proteins.
By defining this new member of the Ngo metal regulon, my work will potentially point to new therapies for this
antibiotic-resistant bacterium. Through its combination of bacterial physiology and genetics, biochemistry, and
cellular microbiology, as well as the professional development opportunities available to me during my graduate
training, this project will provide me with the background and expertise to pursue a career as the leader of an
academic research laboratory in host-pathogen interactions.

Public health relevance
Project Narrative The human pathogen Neisseria gonorrhoeae (Ngo) is the causative agent of gonorrhea and remains a major public health concern due to increasing rates of antibiotic resistance and lack of a protective vaccine. The work will investigate a protein that I hypothesize Ngo uses to acquire zinc in metal-limited conditions. Understanding the metal transport mechanism Ngo utilizes to undermine host-mediated metal limitation will translate into development of targeted new therapies against this antibiotic-resistant bacterium.